From Court to the Community: Improving Access to Evidence-Based Treatment for Underserved Justice-Involved Youth At-Risk for Suicide

PROJECT SUMMARY
Justice-involved youth (JIY) living in the community experience disproportionately high rates of suicidal thoughts
and behavior (STB) and non-suicidal self-injury (NSSI) compared to adolescents in the general population. Many
JIY lack access to evidence-based treatment specifically designed to treat NNSI and STB, thereby increasing
the overall risk of suicide in this population. Further, even when JIY do have access to evidence-based treatment,
treatment initiation in this population is low. The current proposal aims to reduce STB and NSSI among JIY, and
thus reduce mental health disparities in this vulnerable and underserved youth population. Our primary aim is to
implement a systems-level intervention designed to increase access to evidence-based treatment strategies
specifically designed to treat STB and NSSI behaviors for JIY referred to outpatient care by the Rhode Island
Family Court. We will conduct a cluster randomized stepped wedge trial in which 9 distinct community mental
health agencies (CMHA) who serve JIY in the state of Rhode Island will be randomized to receive a standardized
training program. A select number of CHMA administrators and providers will complete semi-structured
qualitative interviews pre-implementation to assess agency/system-level and provider-level factors that may
promote or hinder the uptake of evidenced-based treatment strategies for STB and NSSI in CMHAs serving JIY
living in the community. Quantitative data will assess organizational, provider, and youth characteristics and will
be collected through questionnaires CMHA providers complete and from the electronic medical record pre-
implementation, immediately post-implementation, and 9-months into sustainment. It is hypothesized that at the
systems level, the training program will be sustained for at least one year and up to 3 years by CMHA
administrators. At the provider level, it is hypothesized that training in the use of evidence-based treatment
strategies for STB and NSSI will significantly increase both the use of these strategies and the quality of their
delivery over a year’s follow-up period. At the patient level, we hypothesize that the training program will improve
parental adherence to outpatient treatment and reduce rates of adolescent STB and NSSI that require
emergency medical/psychiatric care in our healthcare system. Our secondary aim is to examine factors that
influence treatment initiation among JIY living in the community. We will enroll 180 caregivers of JIY youth who
screen positive for recent NSSI/STB to test the hypothesis that JIY whose caregivers are randomized to the
psychoeducation/action plan condition, compared to an educational video, will be significantly more likely to
initiate treatment at a CMHA. Caregivers will complete follow-up assessments at 3- and 6-months post-baseline
to assess whether their adolescent initiated treatment and how many sessions the adolescent attended. This
application has strongly aligns with NIMH’s Strategic Objective 3.3: “Test interventions for effectiveness in
community practice settings,” and the goals of the RFA-MH-21-187 to test effective “systems-level strategies for
the detection and prevention of SIB and/or NSSI specifically among underserved children and adolescents.”

Public health relevance
PROJECT NARRATIVE Suicidal thoughts and behaviors and non-suicidal self-injury are disproportionally high among justice involved youth (JIY). This study aims to collaborate with community mental health agencies who serve JIY to enhance the implementation of effective system-level interventions for detecting and treating non-suicidal self-injury and suicidal thoughts and behavior in justice-involved adolescents. This work has the potential to better understand what agency-specific factors facilitate the successful implementation of evidence-based assessment and treatment for suicidal JIY living in the community and will yield practice-relevant information regarding scalability, implementation, and dissemination of treatment in the community.